Spatiotemporal Regulation of Protrusion Dynamics During Intracellular Bacterial Dissemination

PROJECT SUMMARY/ABSTRACT
Infections by intracellular bacterial pathogens are a leading cause of illness and mortality worldwide. Listeria
monocytogenes (Lm) is a gram-positive food-borne pathogen that replicates within the cytosol of host cells and
causes listeriosis, a life-threatening disease that affects newborns, immunocompromised individuals, pregnant
people, and the elderly. A key aspect of Lm pathogenesis is the ability of bacteria to use actin-based motility to
spread into neighboring cells via Lm-induced protrusions. The formation and uptake of Lm protrusions is a multi-
stage process that includes protrusion initiation, elongation, stabilization, and engulfment by neighboring cells.
The host and bacterial factors required for each step of protrusion dynamics have remained unclear. We have
discovered that a host protein, Abi1, localizes to Lm-induced protrusions and is required for efficient Lm cell-to-
cell spread in human epithelial cells. Moreover, prior host factor screens have indicated that Abi1 is critical for
infection by additional intracellular bacterial pathogens. The focus of this proposal is to determine the
requirement of Abi1 and potential host accessory proteins for Lm protrusion dynamics and cell-to-cell spread. In
Aim I, the requirement of Abi1 for cell-to-cell spread will be determined by infecting host cells of different lineages
in which Abi1 expression has been knocked down or knocked out with Lm strains expressing GFP. Assessment
of foci of infections by fluorescence microscopy and plaquing assays will be used to evaluate cell-to-cell spread.
Furthermore, immunofluorescence (IF) microscopy will be used to determine the localization of Abi1 during
infection and to characterize protrusions within wild-type and Abi1-negative host cells. Transmission electron
microscopy will be used to determine differences in the architecture of Lm-induced protrusions in Abi1-negative
cells. In addition, spinning disk confocal live-cell imaging with GFP-Abi1 expressing host cells and Lm expressing
TagRFP will be used to determine the spatiotemporal localization of Abi1 during Lm infection. In Aim II, we will
use host cells expressing full-length and truncated GFP-Abi1 variants with IF microscopy to identify the domain(s)
of Abi1 responsible for Abi1 localization to Lm protrusions. Plaquing assays will be performed to determine if
Abi1 truncation variants can complement cell-to-cell spread in ABI1 knockout cells. We will determine the
requirement of known Abi1 interacting proteins for localization of Abi1 and Lm protrusion formation using RNAi
in conjunction with IF and spinning disk confocal microscopy. Plaquing assays in cells depleted for known Abi1
interacting proteins or the Abi1 interacting proteins and Abi1 will be performed to determine the contribution of
the accessory proteins in Lm cell-to-cell spread. To identify additional accessory proteins that may play a role in
Lm protrusion dynamics and bacterial dissemination, we will determine the complete proteomic profile of isolated
Lm-induced protrusions by mass spectrometry. The proposed studies will provide significant insights into the
role of Abi1 in regulating Lm protrusion dynamics and cell-to-cell spread and provide fundamental knowledge
into a process shared by multiple intracellular bacterial pathogens for dissemination within the host.

Public health relevance
PROJECT NARRATIVE Listeria monocytogenes is a model intracellular bacterial pathogen that uses actin-based motility to spread cell to cell and disseminate within the host. During intracellular infection, bacteria form long pseudopodia-like protrusions that extend from the infected cell and are taken up by neighboring host cells, facilitating direct cell- to-cell spread. The focus of the proposed studies is to determine the spatiotemporal requirement of Abi1, a host cell protein that localizes to L. monocytogenes-induced protrusions, for protrusion formation and cell-to- cell spread.